Understanding and Controlling Macrophage Behavior in Angiogenesis

Project Summary
At the heart of angiogenesis and biomaterial vascularization lies the inflammatory response, orchestrated
primarily by macrophages, which dramatically shift phenotype over time in response to microenvironmental cues.
In the normal response to injury, macrophages are initially pro-inflammatory (aka M1), and at later stages they
are replaced by a mixed population referred to collectively as M2 that upregulate factors associated with
resolution of the wound healing process. The extent of the diversity of this M2 population in particular is not
known. At later stages of angiogenesis and biomaterial vascularization, M2 macrophages are generated 1) via
transition from M1 macrophages, or 2) from direct differentiation of newly arriving monocytes. The differences
between the M2 macrophages arising from each population have not been investigated. Preliminary data
suggest that M1-derived M2 macrophages possess enhanced angiogenic functionality, and that biomaterials
that transiently stimulate the initial M1 phase may enhance the subsequent response to M2-promoting
biomaterials to achieve enhanced vascularization and healing. The overarching hypothesis of this project is that
biomaterials that promote sequential M1 and M2 activation of the same population of macrophages will enhance
vascularization. To test this hypothesis, this work has the following goals: 1) Determine the effects of M1 pre-
polarization on the functional phenotype of M2 macrophages in crosstalk with blood vessels in vitro, using
primary human macrophages, gene and protein expression profiling, and tissue-engineered models of
angiogenesis. 2) Determine the effects of pro-inflammatory pre-treatment on the regenerative effects of IL4-
releasing biomaterials in vivo, using biomaterials that temporally control the phenotype of host macrophages in
a murine hindlimb ischemia model. 3) Determine the angiogenic effects in vivo of a biomaterial-mediated
macrophage cell therapy strategy that intracellularly directs a single population of macrophages from M1 to M2.
This latter strategy may result in particularly beneficial biomaterials for patients who suffer from impaired
leukocyte trafficking, including patients with diabetes, autoimmune disease, or those undergoing
chemotherapeutic treatment for cancer. This work will advance our understanding of how biomaterials can be
designed to leverage both the inflammatory and regenerative functions of macrophages to enhance
angiogenesis, which will allow us to develop new strategies to treat numerous diseases characterized by
pathological angiogenesis, including heart and brain ischemia, atherosclerosis, and diabetes, among many
others. In addition, this project proposes a novel approach to direct tissue revascularization by controlling the
actions of both recruited and exogenously administered macrophages using biomaterials.

Public health relevance
Project Narrative A therapeutic strategy to induce neovascularization of tissues and biomaterials would represent a major breakthrough in the treatment of ischemic tissue disorders, dysfunctional wound healing, and the replacement of damaged tissues. The proposed studies are designed to improve our understanding of how the body naturally orchestrates successful blood vessel growth, and then to apply these principles to the design of novel biomaterials that harness these processes to promote vascularization.